Characterizing A Raphe Chemosensory Amplifier Network

Abstract: This document was not requested per the Grants Management Specialist, Mr. Ty Smith nor is it a required document for the proposed submission.

Public health relevance
Project Narrative: This document was not requested per the Grants Management Specialist, Mr. Ty Smith nor is it a required document for the proposed submission.